Leadership Core

The PNAT program will be led by the Leadership Core[unreadable]Drs. Ring, Benowitz, Swan and Toll. Drs. Ring and Benowitz will serve as co-principal investigators of the program, with responsibility for the execution of the research. The Leadership Core will make major program decisions, coordinate experimental approaches and procedures, and implement PGRN polices (See Section VTII.2 for detailed plans for program operation).